The electrophysiological properties of embryos Transfer

Project Summary
Congenital heart disease (CHD) leads to severe morbidity and mortality in children in the US and worldwide.
Despite this impact on child health, we simply do not understand the genetic causes of CHD. Indeed, we recently
showed that ion channels play a critical role in CHD, LR patterning, and early germ layer specification. We
previously outlined an ion channel signaling network where ERG channels suppress voltage-gated calcium
channels and mTOR signaling enabling the exit from pluripotency to germ layer differentiation. However, this
study raised several additional questions. For example, do the germ layers have different electrophysiological
properties? What are the calcium-responsive transcription factors that activate mTOR signaling? The goal of
this proposal is to answer these questions.
We propose, and our preliminary data support, that ion channels define a new paradigm for cell signaling in early
embryonic cells. Our data support an electrophysiological model where specific germ layer fates are dependent
on an ion channel network. Our overarching hypothesis is that ion channels define electrical membrane potential
and regulate voltage-gated Ca2+ channels that establish an exit from pluripotency towards specific cell fates,
gastrulation, and LR patterning providing a plausible mechanism for our patients with Htx and CHD. Our
electrophysiological pathway then integrates with biochemical signaling pathways that define specific cell fates
in the embryo.
In this proposal, we will focus on understanding the differences in electrical properties of the different germ layers
using both electrophysiological measurements and gene knockdown in Xenopus. We will then also identify the
transcription factors that regulate mTOR signaling in the early embryo. Our published results strongly point
towards ETS and CRE transcription factors, and we will identify precisely which transcription factors play a key
role in mTOR signaling and pluripotency.
A major strength of our proposal is our expertise; we have forged a collaboration between Xenopus
developmental biologists and electrophysiologists that will allow us to rigorously investigate membrane potential
as an embryonic patterning mechanism.

Public health relevance
Project Narrative Congenital heart disease, or “holes in the heart,” is a major cause of infant death in the US. We investigate one possible cause of congenital heart disease, ion channels, that may affect the electrical properties of cells and heart development in the fetus.